Maximizing Peptide Therapeutic Delivery Through Biomodulatory Materials Design

Project Summary
As the biomedical community tackles grand challenges like site-specific pharmaceutical delivery and organ
regeneration, strategies employing simple products serving a singular function are suboptimal. Instead, novel,
multi-dimensional strategies need to be developed to achieve the next breakthroughs especially in fields like
immunoengineering and regenerative medicine. Nowhere is this effort more necessary than in the use of
bioactive peptides where considerable hurdles exist in achieving spatiotemporal control over their delivery. While
a wide range of biomaterials have been employed to attempt to achieve this goal, they have been mostly non-
bioactive in nature minimizing their maximum drug loading and device fabrication potential while often leading to
limited higher order structure of associated peptides. To address this issue, the long-term goal of the Ulery
Laboratory is to engineer the physicochemical properties of biomaterials to allow them to directly modulate cell
and tissue responses. These novel biomaterials, defined as biomodulatory materials, are being utilized
individually or in combination with other bioactive factors to produce desirable biomedical outcomes. Our recent
progress in this research space has focused on leveraging peptide amphiphile micelles to create complex
nanoparticles and hydrogels. By generating novel biomaterials from bioactive peptides, we have been able to
create self-adjuvanting vaccines, anti-inflammatory therapeutics, cell-targeted cancer therapies, and bone
regenerating products. While exciting in its own right, we have been able to achieve these results with peptides
that do not have the peptide chemistry that lends to their stabilization through other means like stapling and
cyclization. In this Maximizing Investigators’ Research Award, we will build on our previous efforts to engineer
peptide-based biomodulatory materials that can serve as translational platform technologies for a variety of
biomedical applications. First, we will use a combination of computational and experimental techniques to
generate design rules for micellar nanoarchitectures to allow for the rapid production of micellar systems from
new bioactive peptides. In addition to nanoparticle shape, we will characterize the influence that other physical
properties such as charge, stability, and product entrapment have on peptide amphiphile micelle function. Finally,
we will focus on programming multiple cell recruitment and differentiation outcomes into hydrogel systems to
achieve coordinated complex bioactivity. These efforts are well suited as a foundation to continue to build our
laboratory’s research program upon including progressing into the new application areas such as treatments for
autoimmune diseases, tumors, and neural disorders.

Public health relevance
Project Narrative Peptide therapeutics have emerged as an exciting alternative to traditional small molecule and protein drugs combining the synthetic flexibility of the former while maintaining the specificity of the latter. While an exciting emerging area, peptides have considerable challenges including their high dosage requirements, difficulty being delivered intracellularly, cleavage by enzymes, and limited higher order structure. To address these limitations, this project explores the rationale design of new biomaterials-based products derived from the therapeutic peptides themselves termed biomodulatory materials for a wide range of potential applications including vaccines, immunomodulation, and spine regeneration.